Core C Transcriptomics

Project Summary/Abstract
Transcriptomic Core (C) provides critical state-of-the-art services to support all of the Projects in this proposal.
Core C will apply whole cell and nuclear single cell transcriptomics to evaluate molecular identity and activated
gene networks in specific neural and non-neural human brain cells, and will use cutting-edge `Large area
spatial transcriptomics (LaST)' to map gene expression across cell types and brain regions at key stages of
human 3rd trimester-term neonatal brain development. The use of these technologies will advance our
understanding of the mechanisms of cell lineage development in preterm and term neonatal human brain and
serve as a high-resolution molecular map against which to measure how perinatal injuries, such as hypoxic
ischemic encephalopathy (HIE) impact the development of the brain. Additionally, Core C will work with project
leaders to develop a battery of novel cell-specific markers for already defined cell types, such as neural
progenitor cells, newly born neurons, microglia, and glial cell lineages, as well as novel markers that will serve
as tools to identify and characterize the newly-described cell types of the neonatal human brain such as the
migrating neuronal streams that have already been discovered during the initial tenure of this proposal.
Core C will be directed jointly by Drs. Kriegstein and Rowitch who have expertise in human brain development
and in single cell transcriptomics and spatial transcriptomics respectively. Dr. Kriegstein will provide oversight
and guidance of day-to-day operations, scheduling and experimental design. Dr. Kriegstein's laboratory has
developed and validated both single cell and single nuclei mRNA sequencing technology recently documented
in two joint publications with the Rowitch laboratory (Velmeshev et al, Science, 2019; Schirmer et al, Nature
2019); the Rowitch laboratory has designed a unique pathway for Large-area spatial transcriptomic (LaST)
mapping of mouse and human brain (Bayraktar et al., 2019, Nat Neurosci; Schirmer et al, Nature 2019);. The
combined use of both of these technologies will enable Projects 1-3 to molecularly profile diverse cell types
including interneurons, oligodendrocytes, and microglia, discover new cell type specific markers, and map the
in situ expression patterns of genes identified through single cell mRNA sequencing. The Core Directors,
assisted by Dr. Dmitry Velmeshev, a talented bio-informatician who will serve as Core Manager, have
developed an organizational scheme for Core C that is designed to meet the complementary needs of all the
projects. They will also assist project leaders and trainees in the PPG in order to optimize design and
execution of their single cell sequencing and mapping projects. In addition, Core C will work with the Scientific
Advisory Committee to maintain the highest standard of quality control and with the Administrative Core (Core
A) to manage operational and budgetary issues. Core C will provide critical support to help achieve the goals
of Projects 1-3 that will, together, provide new insights into human brain development at clinically important
neonatal stages of development.